LONG-TERM FOLLOW-UP OF HUMAN AMYLOIDOSIS

This protocol evaluates factors which influence survival in patients with amyloidosis. We are examining treatment of melphalan/prednisone/colchicine in patients with primary (AL) amyloidosis. Long term efficacy is being evaluated.